Carolina Population Center Research Services Core

The Research Services Core will advance the Center’s research in population science
by providing state-of-the-art statistical, technical and methodological expertise, a
sophisticated, versatile and robust computing environment, and access to professional
staff with a range of different skills that contribute to the production, analysis and
dissemination of data. A successful Research Services core will contribute directly to
the overall aims of this research infrastructure program by supporting identification,
testing, adoption, and diffusion of new approaches and methods in the population
sciences and by managing a group of professional IT and programming staff who make
it possible for Fellows to take on new challenges with the confidence that a
sophisticated well-organized and professional team is backing them up. Specific
activities of the Research Services Core include provision of an IT environment that
supports high performance computing, specialized software, and a secure computing
environment; supporting the collection of primary data, acquisition of secondary data,
and management of large and complex data; and programming support, and
maintaining and enhancing CPC’s data portal for safe and easy dissemination of data
we collect. Additionally, this Core provides researchers with access to statistical,
research design, and methods consulting and will identify and mainstream innovations
in research developed by specific projects so that they are broadly available to other
faculty. The core places a high priority on providing services to junior faculty because
assistance at this career stage can be crucial. The center provides junior faculty and
Early Stage Investigators with full access to Research Services support, and the Core
and unit directors work closely with these faculty.